"Data Resource and Administrative Coordination Center for the Scalable and Systematic Neurobiology of Psychiatric and Neurodevelopmental Disorder Risk Genes Consortium"

PROJECT SUMMARY / ABSTRACT
Our U24 parent grant funds our team to serve as the Data Resource and Administrative Coordination Center
(DRACC) for NIMH’s Scalable and Systematic Neurobiology of Psychiatric and Neurodevelopmental Disorder
Risk Genes (SSPsyGene) consortium. The consortium’s mandate is to functionally and mechanistically
characterize the contribution of 250 genes linked to neurodevelopmental and psychiatric disorders. One of our
goals has been to lead the consortium into a Cloud-based Data Biosphere. This Competing Revision expands
Aim 4 of the parent grant: “Data Processing, Analysis, Integration and Management”, where we propose to
create a FAIR-based Data Biosphere model and a data submission system that supports the data providers
within SSPsyGene. The current four data producing centers (more will join in Fall 2024) are working on 2D and
3D cultures of human induced pluripotent stem cells that are differentiated into neural tissues (organoids), as
well as on live animals. The data centers are contributing a large variety of data formats, including scRNAseq,
spatial transcriptomics, morphometry, behavioral assays, and electrophysiology.
We are seeking support to assemble electrophysiology analysis methods alongside genomics data
analysis in a standardized cloud-based data analysis pipeline. In contrast with genomics, electrophysiology
tracks dynamically changing activity over arbitrarily long time periods at little additional cost. As a result, raw
electrophysiology datasets have become too large to analyze effectively on-site, dwarfing the genomics data.
Our key innovation is a new generative AI-driven multistage data compression method for electrophysiology
data that will dramatically reduce compute times and storage costs while at the same time enhancing data
interpretation. We have delineated a comprehensive cloud-based pipeline built around this compression
pipeline, incorporating Kubernetes clusters for computing, S3-compatible storage, and containerized workflows
managed via Dockstore, all runnable in a secure environment. This architecture will enable the efficient
processing of 30 TB of existing test data along with much larger datasets anticipated in the near future from
SSPsyGene and additional colleagues. We will examine accuracy and speed at different compression levels,
scalability, and cost-effectiveness compared to existing local computing solutions. Our project will create a
more cost-effective, and integrated research ecosystem for electrophysiology data that will benefit not only
neuroscience, but also cardiology, optometry, audiology, gastrology and other research areas that use
electrophysiology data.

Public health relevance
PROJECT NARRATIVE We will develop a cloud-based analysis pipeline for electrophysiology data, which measures the electrical activity of cells, because dramatically large data files are currently being produced by lab-based cardiac and neuronal differentiated cell cultures and from measurements in health-care settings. Unlike genomics data, electrophysiology tracks dynamically changing activity over arbitrarily long time periods, often generating datasets that are too large to analyze effectively on-site, and also, labs use lab-specific formats, preventing standardized data sharing and analysis. Our pipeline will create a unified electrophysiology data type with a user-friendly cloud-based interface, reduce data file sizes by up to 6 orders of magnitude to save on storage and processing costs, and enable research groups to access and analyze data regardless of their local computing capabilities.